Gene duplication and divergence: the bigger picture

Gene duplication and divergence has driven evolutionary innovation in all domains of life. We have learned
a great deal from previous bioinformatic, genetic and biochemical investigations that focused on mutations in
duplicated genes. However, these approaches miss an important biological reality – the context in which a newly
duplicated gene is evolving. Mutations elsewhere in the genome that improve fitness in the face of an
evolutionary challenge may be just as important as mutations in the gene undergoing divergence. Such
mutations may rewire metabolic or regulatory networks in ways that boost fitness in the short run, but may
sacrifice a previously well-evolved function in the process. We term these “expedient” mutations. Expedient
mutations and mutations in duplicated genes are inextricably intertwined as organisms evolve new genes.
We will investigate the role of expedient mutations during evolution of a new protein using a model system
in which that novel protein is required for growth. ∆argC E. coli cannot synthesize arginine. A point mutation
allows E383A ProA (ProA*) to catalyze both its native reaction and the ArgC reaction, albeit poorly. We evolved
∆argC proA* E. coli on glucose + proline (conditions in which there is selection only for improved arginine
synthesis). Growth rate is improved by amplification of proA*, a mutation that improves the ability of ProA* to
catalyze the ArgC reaction, as well as expedient mutations that enhance arginine synthesis by other
mechanisms. We will use our ∆argC proA* model system to address three aspects of gene duplication and
divergence certain to have played a major role in expanding the capabilities of organisms, shaping their
genomes, and determining which lineages win and which lose when environmental conditions change.
In Aim 1, we will determine which expedient mutations that arose during evolution of the ∆argC proA* strain
on glucose + proline are detrimental after an efficient replacement for ArgC has evolved, and how they can be
repaired. In Aim 2, we will investigate how expedient mutations enhance fitness in the more complex situation
when both the original and novel functions of ProA* are required. Finally, in Aim 3, we will address how genome
content, gene context and sequence differences between orthologs affect the process of evolution of a
replacement for ArgC in four different bacterial species.
This work will answer important questions about how new genes have evolved throughout the history of life
and in the present due to new selective pressures imposed by anthropogenic pharmaceuticals and pesticides.
We will gain a better understanding of the interplay between mutations in a new gene encoding a weak-link
enzyme and mutations in the rest of the genome. We will establish what kinds of collateral damage are caused
by expedient mutations, and how those expedient mutations are themselves accommodated. Finally, we will
gain insight into how differences in microbial genomes affect the potential for evolution of a new enzyme in
different bacteria exposed to the same evolutionary challenge.

Public health relevance
Gene duplication and divergence has led to the emergence of huge superfamilies of enzymes, transcriptional regulators, transporters, and signaling molecules. Previous computational and experimental efforts have focused primarily on mutations affecting the gene undergoing duplication and divergence. This project will take a bigger picture approach by examining the role of the entire genome in improving fitness when growth is limited by an inefficient enzyme in the process of evolving by gene duplication and divergence, and by examining how the process is affected by the different genomic contexts found in four different bacteria.